Mechanisms of Radiation-induced Hemolysis

Project Summary
Increased nuclear energy and industrial radiation use as well as nuclear weapons proliferation
have increased the risk for accidental radiation mass casualties or conflict-related radiation
exposure. Radiation countermeasures approved by the U.S. Food and Drug Administration (FDA)
are limited, primarily targeting the repopulation of white blood cell populations following radiation
exposure. Therefore, there is an urgent need to develop countermeasures that address radiation
effects in other cell types. Red blood cells (RBC) undergo non-apoptotic hemolysis following
radiation exposure. The result of rapid RBC lysis is the sudden release of potentially toxic levels
of iron into the serum. Several studies showed that the administration of iron chelators mitigates
multi-organ damage following total body irradiation. Although radiation-induced hemolysis is well
established, the mechanism of radiation-induced RBC hemolysis is not understood, and the forms
of iron released by lysed RBC are not known. Our preliminary data in a murine model of total body
irradiation (TBI) show that hemoglobin (Hb) and carbonic anhydrase II (CAII), proteins critical for
RBC function, are oxidized and inhibited. Reduced CAII activity affects the acid-base homeostasis
in RBC, membrane stiffness, and RBC deformability and fragility. Our data indicate that that
ferritin, transferrin, CD71/transferrin receptor and integrin alphaM/Mac-1 (an iron ion receptor) are
upregulated in several tissue after TBI, suggesting that free iron and ferritin-bound iron may be
increased in the serum. CD163, a high affinity hemoglobin-haptoglobin scavenger, was
downregulated. Based on these results, we hypothesize that Hb and CAII oxidation and CA
reduced function increase RBC fragility, and that free iron and transferrin-bound iron are
increased following radiation-induced RBC hemolysis. This R21 project tests these hypotheses
by pursuing two specific aims: 1) Determine the effects of radiation on Hb and CAII function, RBC
function, and membrane stiffness; and 2) Identify the forms of iron release from hemolysis
following TBI in a murine model. The proposed work is highly innovative because it will address
a novel mechanism of radiation injury and means to counteract radiation injury after the exposure
has already occurred. Results will be significant because the identification of the mechanism of
iron release from RBC will allow the identification of novel targets to mitigate iron-induced multi-
organ injury following total body irradiation.

Public health relevance
Narrative A nuclear accident or terrorist event could result in the exposure of large populations, military and civilian, to high dose radiation. After radiation exposure, high levels of iron are released due to lysis of red blood cells, which has multi-organ secondary toxicity after the direct effects of radiation exposure. This application is aimed at understanding the mechanism of radiation-induced iron release from red blood cells, in order to develop novel radiation countermeasures to mitigate multi-organ damage after total body irradiation.